FAMCICLOVIR (ORAL BRL 42810) IN TREATMENT OF UNCOMPLICATED HERPES ZOSTER

Our objective is to determine the efficacy and safety of famciclovir in the treatment of uncomplicated herpes zoster when given at a dose of 750 mg three times daily for seven days. Patients will be followed for a total of six months. Efficacy of famciclovir will be based on the time to healing of herpes zoster lesions and on the degree of post-herpetic neuralgia.